2024 NASDA Annual Meeting

PROJECT SUMMARY/ABSTRACT
The objective of NASDA’s 2024 Annual Meeting is to provide information on current and emerging feed
and food safety issues impacting agriculture, and to build consensus among the states on regulatory
approaches to these issues. The plenary speakers will give state regulators an opportunity to hear a
national perspective on feed and food safety, something to which they may not be exposed in their
respective states.
NASDA has two membership meetings a year. One is the annual meeting which is hosted in different
state every year; the other is the Winter Policy Conference held in the Washington, DC area. The focus
of the meetings is legislative and regulatory issues of interest to the members. These two occasions and
one additional meeting, held regionally, are opportunities for NASDA members to converse on issues,
make contacts with each other and other leaders, set priorities and goals for the coming year, and meet
face-to-face with NASDA staff and FDA officials.
At recent meetings, NASDA members have stressed the fact that continuous efforts must be made on
the part of the FDA and NASDA members to collaborate and cooperate in discussions on emerging FDA
topics that directly and indirectly affect agriculture. The states and FDA share similar authorities,
missions and responsibilities, and the partners have been working to improve communications. The
passage of the Food Safety and Modernization Act has created a plethora of issues to be discussed and
resolved as we seek to establish an integrated federal-state food and feed safety system. The need for
conversation about the proposed rules and the importance of getting the language in the proposed rules
right the first time cannot be overstated.
The 2024 Annual Meeting presents the opportunity for NASDA members, NASDA staff, and key FDA
leaders to interact with each other, focusing on feed and food safety and regulatory issues, and
promoting partnerships to ensure program success.
The Annual Meeting is three days long, and the agenda includes committee meetings, plenary sessions,
focus sessions, and speakers. NASDA's Food Safety and Nutrition Committee meets during this time to
discuss topics focusing on FDA program areas in which state programs interact. In addition, NASDA
Members and key FDA leadership find time during the meeting for mini-conferences on issues of
interest and concern.
The conference will be held in Indianapolis, IN. NASDA anticipates hosting over 300 participants in
person and an additional 200 participants virtually. Meeting attendees consist of NASDA members and
their staff, NASDA staff, representatives of state and federal regulatory agencies charged with feed and
food safety responsibilities, the regulated industries, and university and research institution
professionals.

Public health relevance
Public Health Relevance Statement The objective of NASDA’s 2024 Annual Meeting is to provide information on current and emerging feed and food safety issues impacting agriculture and to build consensus among the states on regulatory approaches to these issues. The plenary speakers will give state regulators an opportunity to hear a national perspective on feed and food safety, enhancing attendees’ exposure beyond the current events they are dealing with in their respective states. NASDA members and staff work with FDA programs and leadership to ensure that consumers have a safe feed and food supply; 45 NASDA member agencies have cooperative agreements to implement the Produce Safety Rule; 47 state departments of agriculture have feed control authority, and over half of them are performing preventive controls inspections under the Food Safety and Modernization Act (FSMA); approximately 20 state departments of agriculture have manufactured food authority and cooperate with FDA in the administration of these laws. NASDA has collaborated with FDA on major outbreak announcements. Many NASDA member agencies also cooperate with FDA on food safety for milk and seafood. NASDA staff frequently posts FDA press releases in the weekly NASDA News e- newsletter and many NASDA members’ agencies link to FDA’s recall lists. NASDA staff also serve on the Executive Committee of the Produce Safety Alliance.